Defining the lineage, mechanisms of maintenance, and function of a new injury-resistant airway epithelial structure: the hillock

We recently identified a novel airway epithelial structure, the hillock, in the murine trachea and we
present evidence that similar structures occur in the human airway epithelium. Airway epithelial
hillocks are stratified epithelial structures with multiple layers of cells that are distinct from the
classic pseudostratified epithelium that lines most of the airway lumen. They possess novel
polyploid luminal epithelial cells, but completely lack ciliated cells. We now show that these
stratified hillock epithelial structures resist multiple forms of airway injury. We hypothesize that the
stratified structure of hillock cells results in a protective barrier, in analogy to the protective function
of the stratified epidermal cells that lie atop epidermal basal cells. Furthermore, we show that
hillocks contain a unique population of basal stem cells marked by Cytokeratin 13 (KRT13).
These basal cells are characterized by a very high baseline rate of turnover and are capable of
rapidly migrating over denuded airway epithelium. We hypothesize that the diffuse distribution of
injury-resistant airway hillocks facilitates disseminated migration of stem cells that have resisted
severe injury. We show preliminary evidence that hillock basal stem cells, which are the first
highly defined subset of airway basal cells in the murine trachea, are plastic and can produce
normal pseudostratified epithelium after damage to recreate a normal epithelium. Finally, we show
that murine hillocks increase in size and number with age. Interestingly, both smoking-induced
squamous metaplasia and vitamin A-deficiency induced squamous metaplasia have both been
associated with stratified KRT13+ epithelium suggesting they may originate from hillock-like cells.
In this grant application, we first propose to define the lineage and plasticity of hillocks during
homeostasis and after injury using 2 distinct genetic driver lines that are designed to specifically
label hillocks and even more specifically hillock basal cells. We will also determine the functional
significance of hillocks during epithelial homeostasis and after injury repair using diphtheria toxin-
mediated ablation in combination with models of airway injury, with special attention focused on
assessing the role of hillock polyploid cells. Using a combination of an explant model of murine
tracheal regeneration, 2-photon live imaging, and the chemical and genetic modulation of a
human hillock culture system, we will dissect the molecular mechanisms of hillock differentiation
and hillock-mediated injury repair with a focus on the specific role of retinoic acid signaling and
the association of hillocks to squamous metaplasia.

Public health relevance
Narrative We recently identified a novel structure in the airway lining of mice and humans. The cells in these mounded structures, which we have named hillocks for their shape, resist severe injury and act as stem cells that repair the lining of the airway. We propose to study the regulation and function of hillocks to understand how to promote airway repair and understand the role of hillocks in disease.